Pathophysiology of Biliary Disease

PROJECT SUMMARY/ABSTRACT
Our OVERALL OBJECTIVE is to clarify the pathogenesis of Primary Sclerosing Cholangitis (PSC) and identify
new therapies. PSC accounts for 6% of liver transplants, costs ~$125 million annually, affects ~40,000
Americans, has a median survival of ~15 years, and is associated with inflammatory bowel disease and
increased risk of colon, bile duct and gallbladder cancers. There are no regulatory approved drugs for PSC
because its pathogenesis is obscure. We reported that stress-induced cholangiocyte senescence (cell cycle
arrest, apoptosis resistance, bioactive secretome) is a feature of PSC, informing its pathogenesis and revealing
new therapeutic targets. Experiments proposed here extending this observation address the concept that the
cholangiocyte response to injury in PSC is not uniform: some cholangiocytes arrest in the cell cycle (become
senescent) while others acquire a ductular reactive, proliferative phenotype (resist senescence). We discovered
fundamental differences in epigenetic and downstream signaling pathways that influence this binary
cholangiocyte injury response. Our preliminary data show: i) we can isolate enriched subpopulations of
senescent-sensitive and senescent-resistant cholangiocytes with distinct epigenetic signatures from human and
rodent tissue, and from cholangiocyte cell lines; ii) chromatin modifiers, AP1 (transcription factor) and p300
(histone acetyltransferase), establish an epigenetic profile promoting senescence; iii) destabilization of the
effector protooncogene, c-Myc, via the kinase, GSK3, drives senescence and cell-cycle arrest; in contrast,
stabilization of c-Myc via the kinase, AKT, promotes senescence resistance and cholangiocyte proliferation; and
iv) the cholangiocyte subtypes exhibit distinct bioactive secretomes that differentially affect portal fibroblasts
(PF) and hepatic stellate cells (HSC). The data support our CENTRAL HYPOTHESIS that, in PSC, the
cholangiocyte epigenome drives kinase cascades that determine if cholangiocytes develop senescent
or proliferative phenotypes that influence the periductal and bridging fibrogenic responses of PF and
HSC. Our integrated SPECIFIC AIMS test 3 hypotheses. Aim 1 Hypothesis: The epigenetic modifiers, AP1 &
p300, promote open chromatin and active transcription via histone acetylation at senescence-associated
enhancers/promoters and drive cholangiocytes to stress-induced senescence. Aim 2 Hypothesis: The
epigenetic profiles of senescent resistant or sensitive cholangiocytes establish kinase cascades that either
promote proliferation via c-Myc stabilization (AKT) or senescence via c-Myc destabilization (GSK3) and
activation of the senescence effector, ETS1. Aim 3 Hypothesis: Genetic or pharmacologic inhibition of c-Myc or
p300 alters the secretomes of proliferative and senescent cholangiocytes, their communication with PF and
HSC, and periductal and bridging fibrosis. Thus, we will clarify how the epigenome determines the cholangiocyte
injury response, how this binary response drives fibrogenesis, and how pharmacologic modification of the
cholangiocyte epigenome can inhibit PSC progression.

Public health relevance
PROJECT NARRATIVE / LAY SUMMARY This project explores how the cholangiocyte epigenome and downstream signaling pathways influence the progression of Primary Sclerosing Cholangitis, a serious liver disease with no effective therapy except liver transplant. We explore the molecular mechanisms that determine if cholangiocytes arrest in the cell cycle (become senescent) or proliferate (resist senescence), and how these two cholangiocyte populations influence the development of fibrosis. If successful, the results could lead to new and effective treatments.